Biological Sequence Quality Control and Organization

During the past year, we improved our software package VADR
(https://github.com/nawrockie/vadr) for viral sequence annotation
using models based on RefSeq annotation. VADR aligns complete input
sequences to their nearest RefSeq sequence and uses that alignment to
map the RefSeq annotation onto the input sequences. VADR is used by
GenBank to help annotate Norovirus, Dengue virus, SARS-CoV-2 and
metazoan cytochrome C oxidase subunit 1 (COX1) protein-coding gene
sequences.

Most of the development of VADR in the past year was aimed at
facilitating and improving validation and annotation of SARS-CoV-2
sequences. In particular, we made VADR more efficient so that it could
handle more than one hundred thousand sequences per month. In 2021,
VADR was used to annotate and validate more than 1.5 million
SARS-CoV-2 sequences submitted to GenBank. In December 2021, we
released a new version of VADR (v1.4) and switched to using a single
reference model based on the NC_045512 reference sequence for more
consistent and easily-interpretable results. We made additional
releases of the software in January 2022 (v1.4.1) and July 2022
(v1.4.1) which were both minor updates. In March 2022, a manuscript on
the GenBank pipeline for automatic validation and annotation of
SARS-CoV-2 sequences, which involves VADR and so is related to this
project, was published in the journal Database.

In July 2022, we made the first VADR monkeypox virus (MPXV) model
available. It is currently used manually by GenBank curators for
analyzing MPXV sequence submissions.

In August 2021, a manuscript describing the Ribovore software package,
which is part of this project, was published in the journal BMC
Bioinformatics.